Characterization of Diverse Pediatric Cancers in LMIC Using Low-Cost Nanopore Sequencing

Project Summary / Abstract
Virtually fatal 60 years ago, pediatric cancers are now curable for 85% of children who have access to
contemporary treatments and robust supportive care. However, for the 80% of children born in low and middle-
income countries (LMIC), the picture is less promising. When viewed from a global perspective, only 30% of
children in LMIC will survive their diagnosis of cancer, highlighting the stark contrast between high-income
countries (HIC) and LMIC and representing one of the largest disparities in global health.
While curable, cancers in children are not preventable. With no opportunities for prevention, but cost-effective
malignancy-specific treatments increasingly available, an accurate diagnosis often represents the difference
between potential survival and certain death. Modern methods to ascertain a correct diagnosis, such as flow-
cytometry, cytogenetics, and molecular genomics, are standard of care in HIC, but unavailable for many LMIC
treatment centers. Transformative diagnostic approaches utilizing cost-effective, scalable technology are
urgently needed.
As genomic sequencing platforms become more accessible and analytical capabilities expand, integrating
sequencing into childhood cancer diagnostics represents an opportunity to overcome the global “pathology gap.”
Classification of pediatric cancers using short-read RNA sequencing is established in research settings, but the
capital and maintenance expenses of this approach are prohibitive for most LMIC. However, nanopore
sequencing platforms require minimal capital investment and limited lab infrastructure, providing an opportunity
for cost-effective, scalable molecular diagnostic technology in pediatric cancer treatment centers.
We propose to establish and validate robust classification models for pediatric leukemias, extracranial solid
tumors, and lymphomas using nanopore sequencing. We will leverage the close partnership between
investigators at the University of North Carolina at Chapel Hill, St. Jude Children’s Research Hospital, and Indus
Hospital and Healthcare Network in Pakistan to optimize technical and analytics methodologies for nanopore
sequencing of challenging samples, specifically formalin-fixed, paraffin embedded specimens. We will harden
existing protocols for deployment in LMIC and incorporate our analytic pipeline into integrated nanopore
sequencing and base-calling hardware as a step toward affordable point-of-care cancer diagnostics for end
users. Our objective is to develop and validate a cost-effective, sustainable, adaptable solution for the clinically
relevant diagnosis and core genomic classification for childhood cancers in LMIC using a globally accessible
platform.

Public health relevance
Project Narrative Most children with cancer globally are diagnosed in low and middle-income countries, where there is limited access to tools for pathologic diagnosis and, by extension, a high probability a child will receive the wrong treatment for their disease and needlessly die. Recent advancements in nanopore-based platforms for RNA sequencing provide a transformative low-cost, flexible and scalable approach, with potential for broad applicability to the diagnosis of most pediatric cancers. We propose to developa cost-effective nanopore RNA sequencing-based platform to characterize diverse pediatric tumors and prospectively validate its effectiveness in a realistic LMIC setting; in a step toward ultimately curing more children with cancer globally.